Mechanisms of Renal Lipotoxicity

Chronic kidney disease (CKD) is characterized by progressive kidney damage and inability to function. CKD is
currently the leading cause of end stage renal failure, contributing to a growing public health burden. Excess
lipids in the form of free fatty acids (FFA) promote development of tubulointerstitial fibrosis and cellular apoptosis
suggesting that lipotoxicity, the excess accumulation of lipids in non-adipose tissues, contributes to the
progression of disease.
Despite this large public health burden, dialysis and kidney transplant are the only current treatments for chronic
kidney disease. Therefore, my goal is to uncover underlying cellular mechanisms that contribute to the effects of
FFA induced lipotoxicity in kidney tubular epithelial cells and to the development of CKD, the completion of which
may lead to the discovery of new therapeutic targets or treatments.
The Greka lab has expertise in kidney biology and high-throughput screening technologies, which provides an
exceptional environment for me to investigate this problem during my PhD to enhance my cell and molecular
biology skill set as well as my knowledge of lipid and renal biology. Demonstrative of the Greka Lab’s aptitude
to approach this problem, they had previously identified Fas-associated factor 2 (FAF2) knockout (KO), using an
unbiased genome-wide screen, as a top protective hit of palmitate (PA) induced lipotoxicity. Although the role of
FAF2 in lipotoxicity and kidney biology is unknown.
In completion of the proposed fellowship, I intend to describe the mechanism by which FAF2 KO is protective of
PA induced lipotoxicity. I will explore this by identifying the mechanism by which FAF2 KO is protective
of palmitate-induced toxicity (Aim 1) and investigating the consequences of FAF2 KO in murine renal proximal
tubule cells (Aim 2).
Upon completion of these aims I expect to identify new mechanisms of lipotoxicity in kidney epithelial cells that
may elucidate a new therapeutic strategy for treatment of CKD. I will describe how FAF2 and other key mediators
of lipotoxicity modulate the handling of saturated lipids, such as palmitate, and the processes that contribute to
decreased cell viability in the presence of saturated lipids. I will further evaluate the effects of FAF2 KO in mouse
renal proximal tubule cells by examining changes in kidney function and protection from high-fat diet induced
damage. Elucidation of these processes will provide insight to the underlying mechanisms that contribute to FFA
induced lipotoxicity in the kidney and may reveal new targets for CKD related therapeutics.

Public health relevance
The proposed research will provide insights into the molecular responses of kidney cells to saturated lipid induced injury, specifically, the mechanism by which deletion of Fas-associated factor 2 (FAF2) is protective against lipid induced cellular toxicity, known as lipotoxicity. Lipotoxicity can lead to cell injury and death and has been implicated in the pathogenesis of chronic kidney disease. Elucidating the molecular mechanisms of lipotoxicity in the kidney may contribute to the development of therapeutic strategies for diseases lacking treatment options.